Local translation and viral infection in the airway epithelium

Project Summary - Abstract
Multiciliated cells (MCCs) are key components of the airway epithelium playing a major role in mucociliary
clearance, the first line of lung defense against inhaled pathogens. MCCs are well-known targets of viral
pathogens, including influenza A, SARS-COVID2 and respiratory syncytial virus (RSV), often resulting in severe
respiratory conditions with long-term sequelae and morbidity. Still there are major gaps of knowledge on the
mechanisms by which these pathogens trigger airway disease. MCCs require production and apical localization
of a large number of proteins essential for the assembly of hundreds of cilia per cell during multiciliogenesis. The
mechanisms that allow efficient production and local translation of these proteins in MCCs are still poorly
understood. There is evidence that during viral infection, the host’s cellular translation machinery is hijacked to
produce viral proteins for replication. How local translation is established in MCCs and targeted in viral infection
will be studied in this proposal. Our preliminary studies revealed a striking expression of translation initiation
factors (eIFs), ribosomal proteins and nascent polypeptides colocalized with miRNAs, Trinucleotide repeat-
containing 6a (TNRC6a) and Argonaute 2 (AGO2) in immature MCCs undergoing multiciliogenesis. These
signals were concentrated in not yet reported apical cytoplasmic granules, which we named as Localized
Translation granules (LT granules). Surprisingly, unlike other granules traditionally associated with miRNA
function, no enzymes required for mRNA degradation were detected in LT granules. Instead, LT granules were
highly active sites of protein translation. Notably, disrupting Tnrc6a expression, disturbed local translation and
resulted in defective multicilia formation, a phenotype we also observed in RSV-infected MCCs. Here we will test
the hypotheses that i) components of the miRNA pathway recruit subsets of mRNAs and the translation
machinery to LT granules for local efficient large-scale protein synthesis during MCC differentiation; ii) disruption
of this local translation program is a key determinant in the pathogenesis of RSV infection. Thus, we propose to
identify mechanisms that target mRNAs (Aim 1) and recruit the translation machinery (Aim 2) to LT granules in
MCCs, and determine how RSV disrupts these mechanisms to infect the human airway epithelium (Aim 3). The
knowledge generated from these studies will significantly advance our understanding of the mechanisms of local
translation in multiciliogenesis and the pathogenesis of RSV infection in the respiratory tract.
RELEVANCE TO PUBLIC HEALTH: Multiciliated cells (MCCs) are crucial components of the defense
mechanisms of the lung. Viral infections in the immature epithelium of conducting airways can have devastating
effects in infants or adults with compromised respiratory function. Novel information generated from these studies
will advance our understanding of how proper ciliogenesis is regulated, and how viral infections, such as RSV
disrupt cilia formation in immature respiratory tract.

Public health relevance
Project Narrative Multiciliated cells are a crucial component of the defense mechanism of the lung against inhaled biological agents and are a common target of respiratory virus. These studies will advance our understanding of the mechanisms hijacked by respiratory virus to infect multiciliated cells and cause pulmonary disease